Seeking the Biophysical Principles that Govern RTK Activation

PROJECT SUMMARY
Receptor Tyrosine Kinases (RTKs) are single-pass transmembrane proteins that control cell growth,
differentiation, motility, and metabolism. They are very promising drug targets, but the incomplete understanding
of the activation mechanism of the RTKs in the membrane hinders the development of effective and safe therapies.
This proposal is dedicated to the development of new methodologies that can quantify molecular interactions and
can move the field forward. In Aim 1, we will develop a combined Number and Brightness (N&B) and Förster
Resonance Energy Transfer (FRET) methodology that yields both the oligomer size and the dissociation constants
for full length RTKs in live cells. In Aim 2, we will develop a fluorescence-based methodology that yields
molecular ligand binding constants for full-length RTKs in live cells. Along with enabling the acquisition of new
knowledge by the broad scientific community, the work in the aims will yield new insights into critical aspects
of the signaling by the RTKs used in method development.

Public health relevance
PROJECT NARRATIVE Receptor Tyrosine Kinases (RTKs) are very promising drug targets, but the incomplete understanding of their activation mechanism hinders the development of effective and safe therapies. This proposal is dedicated to the development of new methodologies that can quantify RTK molecular interactions and can move the field forward. Along with enabling the acquisition of new knowledge by the broad scientific community, the proposed work will yield new insights into critical aspects of RTK signaling.